Procyanindin A-type dimer: A novel inhibitor of tau aggregation in vivo

Project Summary Basic research has identified β-amyloid plaque formation and tau aggregation as the primary biomarkers of Alzheimer’s Disease (AD), which are hypothesized to be causally involved in AD progression. Molecular interventions of primarily β-amyloid aggregation have over the last decade, however, been met with overt failure. Thus, alternative targets are now essential. Several inhibitors of tau aggregation in vitro have been identified, but only one, methylene blue, is currently being assessed for efficacy in vivo. Most small molecule chemical inhibitors fail to enter the drug pipeline due to insolubility as well as inherent toxicity issues. Consequently, our laboratory has considered naturally occurring molecules present in edible plants as possible alternatives. Plant polyphenols have long been associated with various health beneficial effects owing classically to their anti-oxidant properties. However, distinct bio-activities of certain polyphenolic compounds are now believed to be responsible for a significant reduction in age-related diseases, cancer, cardiovascular diseases, and processes associated with neurodegeneration. We previously demonstrated that an extract of cinnamon containing a procyanidin A-linked trimer molecule (865 Da) was non-toxic and capable of inhibiting tau aggregation in vitro (Peterson et al., J. Alz. Dis., 2009, 17: 585-97). We now show that an aqueous extract of peanut skin (PSE) similarly inhibits tau aggregation. The bio-active component was isolated, and the purified compound contained intrinsic inhibitory activity. The compound was identified as a procyanidin A-linked dimer (576 Da). The corresponding, highly similar B-linked dimer did not inhibit, suggesting a specific interaction between tau and procyanidin oligomers of A-type linkage. Monomeric epicatechin, the molecule from which procyanidin oligomers are derived, do not inhibit, suggesting that the dimer is the smallest procyanidin molecule that retains tau aggregation inhibitory activity. Finally, peanut skin extract was orally administered to a mouse model of Alzheimer’s disease, and preliminary data suggests the potential of the extract to inhibit tau pathology in vivo. In this grant application, we propose to test if purified procyanidin A-linked dimer administered orally to Alzheimer’s disease mice displays efficacy to inhibit tau pathology and the behavioral symptoms associated with AD. We hypothesize that procyanidin A-linked dimer present in a common and inexpensive food source may offer potential as a novel and effective intervention of tau aggregation in humans.

Public health relevance
Project Narrative Our laboratory is interested in the molecular pathology of Alzheimer’s disease with the ultimate goal of discovering novel therapeutics effective in attenuating the disease progression. We have identified a natural compound present in peanut skin as a procyanidin A-linked dimer. The molecule is water soluble and non-toxic, and effectively inhibits the molecular pathology of Alzheimer’s disease in vitro. The goal of this proposal is to test if the purified procyanidin A-type dimer can be orally administered to an Alzheimer’s mouse model to inhibit the molecular pathology and behavioral symptoms of Alzheimer’s disease in these animals. If proven so, the procyanidin A-type dimer may be a candidate compound that holds real promise as a safe, non-toxic, small molecule with potential as novel Alzheimer’s disease therapeutic, or a lead compound that may guide the development of a potential Alzheimer’s disease interventive therapy.